Misperceptions that prevent complete switching to e-cigarettes among adult smokers: A more nuanced communication strategy

PROJECT SUMMARY/ABSTRACT
Smoking is the most dangerous way to use nicotine but fewer than 8% of cigarette smokers successfully quit
each year. While quitting all tobacco and nicotine use is best, completely switching to a noncombustible
nicotine product, like e-cigarettes, can reduce exposure to harmful chemicals and risks for those who cannot
quit. However, many people inaccurately believe that e-cigarettes are as harmful as combustible cigarettes,
which may suppress switching. Limited research exists on underlying reasons for these beliefs, and few
studies have identified educational messages that may be used for adults who smoke to address these beliefs.
More research is needed on comprehensive messages that can target beliefs and effectively communicate the
relative risks of e-cigarettes versus cigarettes, and to assess their potential effects on beliefs, intentions, and e-
cig use. Research is also needed on methodological tools that can be used to identify communication that can
effectively increase message-consistent beliefs and behaviors. Extant research suggests that tobacco
message testing may be enhanced by using neurocognitive measures of message effectiveness, which have
been shown to explain additional variance in intention and behavioral outcomes compared to self-reported
measures alone. Functional near-infrared spectroscopy (fNIRS) is one method for measuring neurocognitive
response that provides unobtrusive, subconscious, objective measures of cognitive processing predictive of
behavior change. The overall aims of the proposed research are to: 1. Identify latent classes of beliefs about
cigarette and e-cigarette harms to inform message development; 2. Develop, pilot test, and refine e-cigarette
educational messages that target prevalent belief classes using neurocognitive and interview responses, and
3. Test finalized messages to assess effects of belief class messages on neurocognitive response, belief and
intention change, and actual e-cigarette use. This study will examine the effectiveness of comprehensive e-
cigarette educational messages tailored to prevalent belief patterns, and whether neurocognitive message
responses can predict message-consistent beliefs, intentions, and behaviors. A comprehensive training plan is
proposed to ensure the implementation of these aims, with objectives focused on 1) refining skills in
neuroimaging techniques, experimental design, and analysis, 2) obtaining experience in designing and testing
relative risk communications, and 3) expansion of skills in advanced quantitative and qualitative methods. The
research and training plans will help me to establish an independent line of research applying communication
neuroscience methodology to tobacco regulatory science research, and to support my pathway to
independence.

Public health relevance
PROJECT NARRATIVE The aims of this proposal are to identify prevalent patterns of beliefs (belief classes) that underlie the perception that e-cigarettes are as or more harmful than cigarettes among adults who smoke, use these belief classes to develop, pilot test, and refine messages employing neurocognitive and interview responses, and test messages for effects on change in e-cigarette beliefs, intentions, and behaviors among adults who smoke. Educational messages for adults who smoke about the relative risks of e-cigarettes versus cigarettes have the potential to improve understanding of harm reduction and potentially increase e-cigarette use, which may reduce exposure to harmful chemicals and the overall harm from tobacco use. Findings from the proposed research can inform future use of belief class messaging as a communication strategy in educational messaging, and the use of neuroimaging to more accurately predict message effectiveness during pretesting.